SUBDERMAL CAPSULES OF LEVONORGESTREL IN FEMALE CYNOMOLGUS MACAQUES

Fifteen intact female monkeys were placed into three groups of five, receiving either an 18, 32 or 16 mg capsule of Levonorgestrel (LNG) placed subdermally in the inter-scapular region on each animal, in groups I through III respectively. One pre-treatment blood sample was obtained, with post treatment blood collections daily from 1 through 7, once per week for 9 months for groups I and II and 6 months for group III, then biweekly for all groups until levels of LNG were undetectable. During this year, only animals from group I had blood samples collected for LNG analysis. Serum LNG was measured by radio-immunoassay. All animals from groups II and III were not monitored during this year because serum LNG was no longer detectable in these animals. LNG levels from group I continued to drop from 0.36 ng/ml (SEM 0.21) on day 1155 to 0.08 ng/ml (SEM 0.06) on day 1365, when all but one animal dropped to undetectable levels. The remaining animal continued to exhibit levels of LNG at 0.32 ng/ml on day 1379, then gradually dropped to undetectable by day 1509. *KEY*Levonorgestrel, Steroidal contraception, Subdermal implants, Synthetic progestin